Expanding insights into FTD disease mechanisms

PROJECT SUMMARY/ABSTRACT
Frontotemporal lobar degeneration (FTLD), which underlies frontotemporal dementia (FTD), encompasses a
group of disorders with significant genetic, clinical, and neuropathological heterogeneity. FTLD is also genetically
and pathologically associated with the motor neuron disease amyotrophic lateral sclerosis (ALS), with some
patients developing both disorders. Understanding the diverse mechanisms governing FTLD pathogenesis is a
fundamental area of interest of my research program, and we pursue this goal by asking impactful questions and
applying innovative techniques. To accelerate scientific discovery, we have adopted a comprehensive approach
that investigates multiple FTLD mechanisms driven by key molecular players like C9orf72, TDP-43, progranulin,
tau and, more recently, TMEM106B. We also place great emphasis on translational research geared towards
identifying much needed biomarkers and therapies, an area of particular importance given that there exists no
treatment for FTLD. Since the funding of my current R35 at the end of 2016, my group has uncovered seminal
findings related to the pathomechanisms mediated by FTLD-associated mutations in C9orf72 and GRN and shed
crucial insight into the consequences of pathogenic TDP-43 and tau deposition in the brain. These findings have
garnered high-impact publications in Science, Nature, and Cell and inspired new and ongoing avenues of
research in my lab. The flexibility afforded by the R35 funding opportunity also allowed us to branch into other
related topics and tackle urgent issues in the broader neuroscience field, including the need for biomarkers and
mouse models for distinct repeat-associated disorders like spinocerebellar ataxias and the recent pressing need
for tools to study and understand COVID-19 and its impact on the brain. Our productivity is influenced by the
excellent research environment fostered at Mayo Clinic, which brings together highly interactive and devoted
neurobiologists, geneticists, neuropathologists and physician scientists, the diversity of my team, and the
numerous collaborations we have forged with world-renowned experts in the field, as well as our dedication to
stewardship and the sharing of information and resources with the scientific community at large. Drawing from
our past work on FTLD, we now propose to explore current cutting-edge questions related to: (1) the molecular
underpinnings of TDP-43 localization and function and the downstream consequences of its dysfunction in
disease, (2) the mechanisms underlying cryptic splicing in TDP-43 proteinopathies and the role of cryptic RNA
and proteins in FTLD, (3) the role of the endo-lysosomal system in the development of TDP-43 pathology and
neurodegeneration, and (4) the emerging role of TMEM106B fibrillogenesis in diverse neurodegenerative
diseases including TDP-43 proteinopathies and tauopathies. We will use a combination of mouse and induced
pluripotent stem-cell modeling, transcriptomics, proteomics, histology, and human tissue analyses to carry-out
our proposed studies and address new and potentially transformative ideas as they emerge.

Public health relevance
PROJECT NARRATIVE Frontotemporal lobar degeneration (FTLD), for which there is presently no cure, is a progressive neurodegenerative disease negatively affecting the personality, behavior and language of patients. Our goals are to define the abnormal processes that contribute to the development of FTLD, as well as devise strategies to monitor and prevent disease progression. The novel insight and translational nature of our findings are expected to transform the field and improve the prognosis for patients with FTLD.